Communicating about nicotine tobacco product standard in cigar products

ABSTRACT This Administrative Supplement will build on the parent grant “Communicating about Nicotine and Differential Risks of Tobacco Products” (R01CA239308 01A1) by expanding its focus to include cigars, little cigars, and cigarillos (cigar products). It will pursue the following specific aim: (1) Quantify the relative importance of different types of information in communications about reduced nicotine in cigars using a discrete choice experiment (DCE), including assessment of differential responses by race, sex, educational attainment and health literacy). Results from this project can enhance FDA’s regulatory actions around product review and product standards for cigar products and FDA’s and other agencies’ communication efforts that address the potential health equity effects of different communication strategies across racial or ethnic minority groups.

Public health relevance
PROJECT NARRATIVE This Administrative Supplement will build on the parent grant “Communicating about Nicotine and Differential Risks of Tobacco Products” (R01CA239308 01A1) by expanding its focus to include cigars, little cigars, and cigarillos (cigar products). The results from this project will contribute to the parent grant’s aims and will directly inform FDA’s communication efforts and policy around reduced nicotine in cigar products.